The impact of antiretroviral therapy on fetal immune system development in SIV-exposed rhesus macaques

SUMMARY
The use of antiretroviral therapy (ART) in pregnant women living with HIV is an effective way to prevent
mother-to-child transmission. However, HIV-exposed, but uninfected (HEU) children experience higher mortality
from common infections and severe respiratory disease. However, the independent and combinatorial effects of
HIV and ART on fetal immune cell development remain unknown. We propose to utilize the well-established
rhesus macaque model of ART-treated simian immunodeficiency virus (SIV) infection to test our hypothesis that
maternal SIV and ART exert differential effects on the development and maturation of the fetal immune
system, resulting in dysregulated functional responses. To address the differential effects of suppressed
SIV infection and ART, we will study three experimental groups of females. In the SIV/ART group, females will
be infected with SIV and then suppressed with ART before undergoing timed-mated breeding. We will have two
control groups: an ART-only group and an untreated/uninfected healthy pregnancy group. We acknowledge that
the ART-only group is not a clinically relevant scenario, but necessary in the context of the proposed studies to
distinguish the contribution of ART per se to the fetal immune phenotype exhibited by the offspring of SIV/ART
dams. We do not have an untreated SIV-infected group, as this is not relevant to the vast majority of pregnant
WLWH. GD130-135 fetuses will be obtained via Caesarean section and studied as outlined in the following
Specific Aims. Aim 1. Determine the effects of maternal SIV/ART or ART on fetal immune system function.
HEU children exhibit altered lymphocyte function and blunted responses of monocytes to pathogens. However,
little is known about the effects of HIV/ART and ART exposure on lymphoid and myeloid cell activation during
fetal development. Therefore, we will study the effects of SIV/ART or ART on both the innate and adaptive arms
of the fetal immune system in circulation and in fetal tissues using a combination of flow cytometry, functional
assays, and single-cell transcriptomics. Aim 2. Determine the effects of maternal SIV/ART or ART on fetal
hematopoiesis. SIV/ART or ART may impact fetal immune system development by altering fetal hematopoietic
stem and progenitor cells (HSPCs). Therefore, in this aim, we will isolate HSPCs from the fetal liver and fetal
bones and determine the transcriptional landscape and functional reconstitution abilities of HSPCs from
SIV/ART, ART alone, and control fetuses. Given the increasingly prevalent use of ART in women of reproductive
age, this study will further our understanding of the effect of ART on fetal immune development. The ultimate
goal of the proposed studies is to identify fetal immune system developmental pathways that can be targeted by
therapeutics and interventions to improve immune outcomes for this vulnerable population of infants.

Public health relevance
NARRATIVE The use of antiretroviral therapy (ART) for pregnant women prevents mother-to-child HIV transmission. However, the HIV-exposed, but uninfected children experience higher mortality from infections. We will use rhesus monkeys to determine how SIV/ART impacts the fetal immune system.